Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's Disease (MAITC): Pilot (AD ADRD Focus)

PROJECT SUMMARY: AD/ADRD Pilot Core
The Alzheimer's Disease and Related Dementias (AD/ADRD) Core plays a central role in achieving the goals
of the Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's Disease
(MAITC) by identifying, selecting, advising, and helping to translate innovative pilot projects that use emerging
AI-enhanced technologies to address clinically and societally unmet needs in AD/ADRD. The AD/ADRD Pilot
Core will draw on the collective clinical, scientific, and technical expertise within MAITC and the valuable input
of our Stakeholder Core and Industry Advisory Board to complete the following specific aims: 1) Solicit and
select the most meritorious pilot studies that will develop and test novel AI-enhanced technologies that address
clinically important questions in AD/ADRD; 2) Provide mentorship, oversight, and resource supports for pilot
project investigators; 3) Assist pilot project investigators in refining their methods and translating their
technologies for clinical, industry, and research use. The AD/ADRD Pilot Core Leaders (Drs. Jasmeer
Chhatwal and Deborah Blacker) will work MAITC’s other core leaders to coordinate and oversee the pilot
project process. The AD/ADRD Pilot Core will solicit pilot projects from the training programs, departments, and
centers at universities and research institutions across the nation, drawing on an extensive pool of existing
investigators who have expertise in areas such as neurology, psychiatry, geriatrics, technology, computer
science, and artificial intelligence. Example topic areas for AD/ADRD pilot projects include: (1) Assessing
cognitive impairment-related safety concerns in the patient's home environment; (2) Assessing responses to
medical and behavioral interventions and promotion of healthy, potentially-protective behaviors in patients with
cognitive impairment; and (3) Informing critical but difficult decisions regarding level-of-care transitions and the
need for caregiving assistance inside or outside the home. Once selected, each pilot project leader will be
assigned two mentors (at least one of whom will have AD/ADRD clinical expertise) who will provide research
guidance and facilitate access to needed resources. The AD/ADRD Pilot Core will work with the other MIATC
cores and the AITC Coordinating Center to ensure scientific integrity, rigor and reproducibility, and to facilitate
IRB approvals, human subject safety, financial management, and regulatory approvals. The AD/ADRD Pilot
Core will help pilot investigators identify critical next steps to move their innovations closer to clinical and
research use. To this end, we will provide resources to pilot investigators to refine their technologies, make
industry contacts, and develop new grant proposals to accelerate the movement of novel technologies towards
the ultimate goal of the AD/ADRD Pilot Core—to improve the care and quality of life for patients and caregivers
affected by AD/ADRD.